An Organ-on-Chip Approach to Evaluation of Reproductive Health, Aging and Disease inWomen

Project Summary/Abstract:
Uterine aging is a key factor in the age-related decline of women’s health and is associated with
infertility, poor pregnancy outcomes and increased cancer risk. Spaceflight has been shown to
rapidly induce symptoms that mimic aging in humans, as well as reproductive health in animals.
Moreover, more and more female astronauts are experiencing long-duration tours in space with
even longer durations are expected for Mars flight and future space endeavors. There is therefore
a critical need to improve understanding of the mechanisms of uterine aging and the impacts of
spaceflight on reproductive health. At the same time, there is a critical need to identify therapeutic
approaches that can repair or protect against uterine aging. We therefore propose to adapt our
microfluidic model of the endometrium to develop a µfluidic Human Uterus-on-chip to study
Reproductive Aging (UHURA). For establishment of UHURA we propose to integrate uterine
smooth muscle cells to our current endometrial model composed of endometrial epithelium,
stroma, and endothelium and integrate complex hormone exposure protocols that mimic the
menstrual cycle. Models will be established across multiple ethnicities and age ranges to identify
population differences and improve understanding of the mechanisms of uterine aging. In the
UG3 phase we will conduct extensive studies to validate model compatibility with spaceflight
challenges, integrate with Redwire’s MVP spaceflight-worthy hardware, which is currently
deployed at the International Space Station-National Laboratory (ISS-NL), and ensure UHURA is
spaceflight ready. We will also conduct a 28-day or 56-day, one or two menstrual cycles,
experiment in the MVP system at the ISS-NL. Effluent will be collected and properly stored, and
chips fixed prior to return to support physiologic and multiomic analyses. Pathway models to
support mechanistic characterization will be constructed from the multiomic data. We will also use
our existing AI/ML network modeling techniques to identify drug targets and existing drugs to
serve as potential candidates for therapeutic treatment of uterine aging. Finally, in the UH3 phase,
we will elucidate the protective/anti-aging effects of known and newly identified candidate
therapeutic compounds (quercetin and candidates from UG3). Dosing, safety, and administration
route preclinical data will be collected on ground and a carefully planned efficacy experiments at
the ISS-NL will be conducted. At the end of the UH3 phase, we will prepare for FDA
presubmission.

Public health relevance
Project Narrative: Spaceflight exposure induces physiological changes in the reproductive system, mimicking many of the hallmarks observed in reproductive aging that lead to infertility and cancer. As the average age of first-birth in women continues to increase, it is critical we identify approaches that can effectively act in an anti- aging capacity and reduce the economic burden of fertility treatments, which is projected to grow at a CAGR of 8.3% per year over the next 10 years. We propose to develop a uterus-on-chip that can be cultured and remotely assessed in a spaceflight-worthy system to study microgravity-induced aging in uterine cells isolated from a diverse population of young and aged premenopausal women and to identify and evaluate therapeutic approaches for stopping, reversing and/or repairing uterine aging toward improving long-term fertility and prevention of common illnesses, including endometrial cancer.